Adjuvant Comparison and Characterization (HIV)

The goal of the Adjuvant Comparison and Characterization (ACC) program is to support side-by-side comparison of adjuvants in combination with clinically relevant vaccine/antigen platforms, and to establish both systemic and tissue-specific immunological profiles (“immune fingerprints”) of adjuvants that work through different mechanisms. A major challenge for HIV vaccine development is learning how to induce robust and durable antibody responses that protect against mucosal infection. A critical step on the path to overcoming this challenge are developing adjuvants that appropriately stimulate robust and durable immune responses. The goal of this project is to assess the impact of 3 different adjuvants on enhancing the magnitude and durability of neutralizing antibody responses against HIV Env.